American Psychopathological Association 2023 Annual Meeting

PROJECT SUMMARY/ABSTRACT
This application requests R13 funds for the 2023 conference of the American Psychopathological Association
(APPA) on the topic “Complexity in Psychopathology: One Size Does Not Fit All.” This topic is timely because
of the growing recognition that complexity and heterogeneity are perhaps the most important challenges to
progress in research into causes, prevention, and treatment of psychiatric conditions, including substance use
disorders. We will explore several avenues of research for identifying and embracing sources of complexity in
research as an opportunity to better address psychopathology in both clinical and population-based samples.
The mission of APPA, since its founding in 1910, has been to (1) support the investigation of disorders of mind
and behavior, including their biological underpinnings and psychosocial substrates, and (2) promote the
development of junior scientists. The APPA holds an annual meeting focused on a different topic each year.
Presenters and attendees are widely diverse in terms of discipline and area of expertise. The unique all-
plenary format of the APPA meeting stimulates an exchange of information, concepts, methods, new findings,
current controversies, and pressing gaps in knowledge that is facilitated by the diversity of the presenters and
the audience. The aim of the 2023 conference is to provide an exciting scientific meeting in this unique format
with the goal of impacting the field by stimulating new research directions, collaborations, and – for junior
scientists and individuals from underrepresented groups – new connections and career opportunities.
Conference presenters include distinguished leaders in their fields (e.g., NIH institute representatives,
university department chairs, center directors, and investigators in psychiatry, psychology, epidemiology,
genetics, and neuroscience) and junior scientists with potential to lead the next generation. Presentation topics
include: keynote lectures on “Personalized medicine” and “Making sense of complexity in psychiatric disorders”
and panels on “Data: Understanding and handling sources of variability in signal and noise”; “Development:
Homotypic continuity or pluripotent syndromes?”; “Diagnosis: Over- and under-specificity”; “Heterogeneity of
treatment response – what is it and how can we learn from it?”; and “Biology: Variable patterns, no mapping
from biology onto psychopathology… what is going on?” Many activities are designed specifically for junior
scientists (students, fellows, early-career investigators), including a workshop, breakfast roundtable with senior
scientists, oral poster presentations to the entire APPA audience, and mentorship of more junior attendees by
APPA Council members and Fellows. Funds are requested primarily for awards that will provide the benefits of
2023 APPA attendance to junior scientists and to investigators from underrepresented groups who would
otherwise not be able to participate in the meeting. Such attendance is designed to attract junior scientists to
become members of the next generation of researchers and members of underrepresented groups to become
involved in research in our field. Additional funds are requested to cover some service costs for the meeting.

Public health relevance
PROJECT NARRATIVE Despite substantial investment over several decades, research into the causes and prevention of mental/behavioral illness, including substance use disorders has not led to hoped-for breakthroughs for our patients and their families due to the complex nature of these disorders and heterogeneity in patient presentations and outcomes. The 2023 conference of the American Psychopathological Association (APPA) will embrace this heterogeneity by focusing on “Complexity in Psychopathology: One Size Does Not Fit All,” bringing together a diverse group of senior and junior scientists who will hear and discuss presentations given by distinguished leaders in psychiatry, psychology, epidemiology, genetics, and neuroscience. This R13 grant will facilitate the conduct of the conference and allow the attendance of junior scientists and investigators from underrepresented groups who may otherwise not be able to afford to participate and who will join the next generation of leaders in this area.